Development of a safer stem cell-based diabetes therapy via suicide gene-mediated ablation of proliferative cells

Project Summary/Abstract
Diabetes represents a growing global health crisis. Despite continuous advancement in medical management of
diabetes, achievement of good blood glucose control remains elusive for many patients. Evidence from patients
who receive donor pancreas or islet transplants demonstrates that replenishment of pancreatic islets can restore
euglycemia. Unfortunately, the relative scarcity of such organs, plus the lifelong burden of immunosuppression
required for their maintenance, puts such therapy out of reach for a majority of diabetics. In this proposed project,
Regenerative Medical Solutions (RMS) will build upon its success in generating pancreatic islet-like clusters
(ILC) from genetically engineered induced pluripotent stem cells (iPSC) to produce a cell-based diabetes therapy
that can be manufactured in abundant quantities, and that will not require immunosuppression for graft
maintenance. Specifically, RMS will extend its partnership with Pluristyx, which has created an iPSC line (iACT)
with two novel features: 1) the over-expression of 7 immunomodulatory transgenes which enable it to evade
destruction by the host immune system without triggering a “missing self” response; 2) the integration of
FailSafeTM technology, which facilitates the elimination of dividing cells from an engrafted cell population via the
administration of the FDA-approved drug ganciclovir. The utility of the FailSafeTM system for elimination of
proliferative cells from ILC grafts was demonstrated in our recently concluded SBIR Phase I project. In the current
proposed project, RMS will work in partnership with the University of Wisconsin-Madison to demonstrate that
ILC produced from iACT cells can restore euglycemia in a mouse model of diabetes, and that these ILC can
evade rejection by the immune system of humanized mice. Further, RMS will demonstrate the utility of two
independent methods of ensuring graft safety in vivo. First, the FailSafeTM system will be used to control
undesired graft outgrowth in vivo while retaining graft function. Second, antibodies developed for cancer
immunotherapy will be used to facilitate graft elimination by the immune system of humanized mice. Following
completion of the proposed project, extension of RMS’s ongoing manufacturing partnership with Pluristyx will
facilitate seamless transition toward cGMP production of the cell therapy and evaluation in IND-enabling
studies.

Public health relevance
Project Narrative Transplanting diabetic patients with more insulin-producing cells is an attractive way to reverse their diabetes, but until now the only way to get new cells was from organ donors, and required giving the patient immunosuppression so the replacement cells would not be rejected. In this project, Regenerative Medical Solutions will make replacement insulin-producing cells that can be made in unlimited numbers, and demonstrate that the cells are safe and will not be rejected by the immune system. These new insulin-producing cells could be a safe and effective therapy for many diabetic patients.